The FMF Connect Teacher Companion Website: developing and testing an FASD-informed intervention for teachers

PROJECT SUMMARY/ABSTRACT
Fetal alcohol spectrum disorders (FASD) are highly prevalent yet underrecognized neurodevelopmental
disabilities. Despite many being cognitively able, children with FASD are at risk of poor academic performance and
school disruption including dropout, suspension, and expulsion. Deficits in executive functioning and self-regulation
likely contribute to this risk. Teachers often do not receive effective training on how to support their students with FASD,
and are frequently unaware of the effects of this neurodevelopmental disability on learning and behavior. Specifically,
lack of training on FASD may lead teachers to interpret behavior as willful, rather than as a result of the disability, which
can result in use of less effective behavior management strategies, and the teacher feeling frustrated and unsuccessful.
The Families Moving Forward (FMF) Program and its derivative mobile health intervention, FMF Connect,
provide an ideal framework to inform a scalable intervention for teachers. The FMF Program is a scientifically-validated
behavioral consultation program, developed at Seattle Children’s Research Institute/University of Washington. Parent
participants in development and initial trials of FMF Connect have emphasized the need for materials to share with
teachers and school staff, and have specifically called for a teacher component to FMF Connect. The proposed project will
address this need by developing and testing the FMF Connect Teacher Companion website.
The aims of the proposed project are to 1a) utilize the ADAPT-ITT framework and incorporate stakeholder
feedback to adapt materials from the FMF Program and FMF Connect to be relevant to teachers’ needs and the classroom
setting; 1b) build a website incorporating these adapted materials and principles of effort-optimized interventions to
increase engagement with digital interventions; and 2) pilot the website to determine feasibility for a larger trial, including
technological functionality and study design acceptability.
This project is essential to increase teacher knowledge of FASD and reduce barriers to quality services for
children and families affected by FASD. This will be the first theory-informed and empirically-derived digital FASD
intervention for teachers; it will be iteratively developed and informed by stakeholder feedback, ensuring its relevance in
meeting teachers’ needs. It will also use ADAPT-ITT, a systematic and evidence-based framework to guide development,
making it grounded in theory and methodologically sound. The proposed intervention will be self-directed and accessed at
will, in contrast to an in-person training which happens at a given time for a given duration. It will also increase
accessibility of evidence-based materials for teachers.
The proposed project will also provide comprehensive mentored training to prepare the PI for a career as an
independent investigator. Under the guidance of experts in the FASD, intervention, and school consultation fields, the PI
will gain essential competencies in models of intervening in educational systems, theory and data-driven intervention
development, and technical skills in intervention dissemination.

Public health relevance
PROJECT NARRATIVE Fetal alcohol spectrum disorders (FASD) affect an estimated 2-5% of school-aged children. Despite this relatively high prevalence, teachers often do not receive adequate training on the effects of FASD on learning and behavior, or effective strategies to support their students with this condition. This project will develop and pilot an FASD-informed website for teachers, incorporating materials adapted from the Families Moving Forward Program, an empirically validated parent intervention specialized for FASD.